Developing Lysine Methyltransferase SETD8 Selective Inhibitors for Treating Multiple Myeloma

PROJECT SUMMARY
Multiple Myeloma (MM) is an incurable plasma cell malignancy and is the second most common hematologic
malignancy. SETD8 (also known as SET8, PR-Set7, or KMT5A) is the lysine methyltransferase that is
responsible for monomethylation of histone H4 lysine 20 (H4K20me), an important histone methylation mark.
SETD8 also monomethylates non-histone substrates such as the tumor suppressor p53 and replication factor
PCNA, causing suppression of p53-dependent transcriptional activation in cancer cells and promoting cancer
cell proliferation. Consistent with this, SETD8 is overexpressed in numerous cancers. In particular, we recently
reported that SETD8 is overexpressed in relapsed primary MM and high SETD8 expression is associated with
poor prognosis. Importantly, SETD8 knockdown (KD) effectively suppressed the proliferation of SETD8-high MM
cells, but not SETD8-low MM cells and normal cells. Moreover, primary malignant plasma cells are particularly
addicted to the methyltransferase activity of SETD8. We therefore hypothesized that pharmacological inhibition
of SETD8 could be a novel and effective therapeutic strategy for the treatment of MM. In our preliminary studies,
we discovered UNC0379 (the first SETD8 selective inhibitor), MS453 (the first SETD8 selective covalent
inhibitor), and MS2928 (the most potent and selective SETD8 inhibitor to date). Inhibition of SETD8 by UNC0379
reduced H4K20me, induced cell-cycle defects and apoptosis, and suppressed the growth of MM cell lines and
primary MM cells without significant toxicity in non-myeloma cells. Furthermore, MS2928 reduced H4K20me
more effectively than UNC0379 and effectively inhibited the growth of SETD8-high MM cells, but not SETD8-low
MM cells and normal cells, thereby phenocopying the effect of SETD8 KD. Importantly, MS2928 was bioavailable
in mouse pharmacokinetic studies and significantly inhibited tumor growth in vivo in two MM cell line xenograft
mouse models without apparent toxicity. Encouraged by these promising preliminary results, we propose to
optimize our SETD8 inhibitors into in vivo chemical probes and evaluate SETD8 selective inhibitors in MM cellular
and mouse models to further test and validate our therapeutic hypothesis. The optimized SETD8 inhibitors to be
generated in this project will also be invaluable chemical tools for assessing the therapeutic potential of SETD8
inhibition in other SETD8-overexpressing cancers, and can be further optimized into drug candidates in the future
and ultimately translated in the clinic for cancer patients.

Public health relevance
PROJECT NARRATIVE SETD8, a lysine methyltransferase, is overexpressed in multiple myeloma (MM) and its high expression levels correlate to poor survival in MM patients. The proposed research aims to discover novel SETD8 selective inhibitors as in vivo chemical probes, which can be further optimized into drug candidates in the future and translated in the clinic for MM patients. Thus, the proposed research is directly relevant to public health.